FENTANYL MANAGEMENT OF POSTOPERATIVE PAIN IN CHILDREN AND ADOLESCENTS

Pediatric inpatient postoperative patients who are expected to require treatment for at least 24 hours with an opiod analgesic for management of moderate to severe postoperative pain will be given E-TRANS (fentanyl) at 25 ug/on-demand dose to evaluate the drug's safety and efficacy for pain management.